Developing glycosylated RNAs as novel clinical targets for aggressive prostate cancer.

PROJECT SUMMARY
This exploratory proposal will be the first to characterize glycosylated RNAs in the context of human prostate
cancer (PCa). PCa is the most prevalent form of non-skin cancer in males and second leading cause of
cancer-related deaths among men. 20% of men diagnosed with PCa will progress to fast-growing, advanced
disease. There are no curative treatments for PCa that has spread to distant sites and the 5-year survival rate
for metastatic disease is only 30%. As high-grade PCa often leads to poor prognoses, it is imperative to better
understand these pathologies and improve patient stratification methods as well as therapeutic treatment
options to increase patient survival. Noncoding RNAs are widely misexpressed in PCa patients and act as key
tumor suppressor genes, pro-oncogenic factors in the prostate. Noncoding RNAs harbor a large range of post-
transcriptional modifications (m6A, inosine, pseudouridine, 2'-O-Me, A-to-I editing, 3’ uridine tailing) that are
important for RNA maturation, folding, expression, and nuclear transport. Dysregulation of these post-
transcriptional modifications are associated with tumor growth, invasion, angiogenesis, immune response and
disease recurrence. Noncoding RNAs were serendipitously discovered to carry glycosylation modifications
when cultured human and mouse cells were metabolically labeled using bioorthogonal chemistry methods
normally employed for glycosylated protein and lipid enrichment. Glycosylation is an intricate process that
typically involves the covalent attachment of carbohydrates onto proteins and lipids as the biomolecules move
through the secretory pathway. Aberrant protein/lipid glycosylation contributes to tumor growth, metastasis,
and immunosurveillance evasion and is being utilized as cancer biomarkers. We hypothesize that RNAs
require glycosylation for cell signaling to maintain prostate homeostasis and cancer prevention and therefore
the glycosylated state of RNA will correlate with prostate tumorgenicity. In support of this rationale, we
confirmed using click chemistry and northern blotting that glycoRNAs exist and with differing abundance in
human prostate cells. Specific Aims: This proposal will use two independent methods, metabolic labeling with
azide click chemistry and lectin-based purification, to classify glycoRNA distribution from a panel of human
prostate cell lines differing in their metastatic potential and hormone sensitivity. Aim 1 will unbiasedly determine
if small versus large noncoding RNAs are preferentially glycosylated in the prostate, if these glycoRNAs share
features for N- or O-linked sugars, and identify these species using RNAseq. In Aim 2, fractionation methods
and chemical inhibitor studies will determine the PCa-associated glycoRNA subcellular localization, possible
exosome enrichment and characterize these carbohydrate moieties via mass spectrometry. In Aim 3, the
Ptenpc-/- Smad4 pc-/- double knockout mouse model will be employed to characterize glycoRNAs from living
animals throughout a prostate cancer progression time course. This work will lead to novel insights into how
RNA modifications impact PCa progression and identify first-in-class clinical tools to improve patient outcome.

Public health relevance
PROJECT NARRATIVE Prostate Cancer is a serious health crisis in the United States and remains the second leading cause of cancer-related male deaths despite implementation of new screening methods and therapeutic drugs for this disease. Glycosylation, involving the covalent attachment of carbohydrates onto proteins and lipids, is shown to impact their molecular stability, cellular localization, biological function and malignancy - but virtually nothing is known about the new field of glycosylated RNAs (glycoRNAs) or their role in human disease such as prostate cancer. Innovative/exploratory work described in this proposal employing a spectrum of human prostate cancer cell lines and an in vivo mouse model for prostate cancer will drastically improve our understanding of glycoRNA mechanisms involved during prostate tumor progression and lead to novel RNA-based biomarker and treatment strategies for lethal prostate cancer.